Metalloenzyme-guided discovery of new RiPP natural products

Project Summary/Abstract
Rising antibiotic resistance and the emergence of multi-drug resistant pathogens requires
the discovery of new drug targets and therapeutics. Currently, the most prominent source of new
medicines is natural products, or secondary metabolites. The proposed research involves the
investigation of biosynthetic gene clusters (BGCs) relevant to pathogenesis and utilizes
genome mining of natural product BGCs containing metal-dependent enzymes as a query
to uncover natural products with novel chemical structures. Metalloenzymes are responsible
for many unusual chemical reactions in natural product biosynthesis. We recently identified a
copper-binding natural product from nontypeable Haemophilus influenzae (NTHi), which we
termed oxazolin. Since oxazolin is required for NTHi to infect human cells, its biosynthesis may
serve as an ideal drug target. The core enzyme in oxazolin biosynthesis is a multinuclear non-
heme iron-dependent oxidase (MNIO), which belongs to a poorly understood family of enzymes
that produce ribosomally synthesized, post-translationally modified peptide (RiPP) natural
products. We hypothesize that oxazolin serves a protective role for NTHi, chelating toxic levels of
copper that human cells employ to stave off infecting pathogens. Aim 1 (K99 Phase) of the
proposed research involves structural and functional characterization of copper-bound oxazolin
and investigation of another oxazolin from the increasingly multi-drug resistant pathogen
Pseudomonas aeruginosa. The latter half of this proposal, which will take place during the R00
Phase, builds on initial genome mining for metalloenzyme-containing RiPP BGCs to uncover
novel chemical transformations in natural product biosynthesis. Genome-mining for other MNIOs
revealed an operon from Streptomyces laurentii encoding two MNIOs and a secreted natural
product; Aim 2 involves determining the function of each enzyme in this BGC and the structure
of the natural product it produces. At least one of the MNIOs is predicted to carry out a new
chemical reaction for this family of enzymes. A second growing family of iron-dependent enzymes
in natural product biosynthesis is the heme oxygenase-like dimetal oxidases (HDOs). Mining for
RiPP BGCs with HDOs identified an operon in Paraburkholderia diazotrophica encoding three
HDOs of unknown function and an efflux pump, which likely facilitates secretion of the final
product, perhaps to serve as an antimicrobial. Aim 3 includes characterization of each enzyme in
the biosynthetic pathway and structure-function investigation of the HDOs. Not only will this line
of inquiry reveal new natural products, but it will also provide biochemical insight into two families
of iron-dependent enzymes with high biosynthetic value.

Public health relevance
Project Narrative The widespread availability of genomic information and advances in bioinformatic tools have enabled new methods of natural product discovery. Natural products play an important role in medicine for their antibacterial, antifungal, and anticancer properties. The proposed projects use genome mining of metalloenzymes to guide the discovery and characterization of novel natural products, which will reveal new drug targets and potential therapeutics as well as expand the repertoire of biochemical reactions performed by metalloenzymes.